Orbitrap Astral for Wayne State Proteomics

Project Summary/Abstract
The goal of this proposal is to bring a Thermo Fisher Scientific Orbitrap Astral mass spectrometer with
a High-Field Asymmetric Waveform Ion Mobility Spectrometry (FAIMS Pro Duo) devise, an Ardia
Instrument Control and Data Management system plus a nano-LC to the Proteomics Core at Wayne
State University. The Proteomics Core supports an extensive user base including 7 Major Users and 19
Minor Users who have contributed to the proposal and who have NIH-funded projects that will be advanced
by having access to the Orbitrap Astral. The Proteomics Core at Wayne State also supports the Karmanos
Cancer Institute and the P30 funded Cancer Center as well as the NIEHS funded CURES P30 Center and
CLEAR P42 Superfund Center. This Orbitrap Astral has unique capabilities for deep profiling of complex
proteomes using Data Independent Analysis (DIA) acquisition. Advances in the Orbi Astral that make
it unique for DIA are the 200 Hz scan speed with 80,000 Resolution and superior sensitivity. These
features allow the Astral to acquire DIA data using 2 Da windows, something no other MS system can
achieve. The new mass analyzer in the Orbitrap Astral make it an exceptional instrument for DIA
proteomics. Combined with the experienced mass spectrometrists in the Core, the Orbitrap Astral will
be a major asset to research programs of NIH-funded investigators at WSU and in the SE Michigan
region. As investigator needs have evolved they have developed an increased need for higher resolution,
greater sensitivity and higher mass accuracy proteomic mass spectrometry. The Orbitrap Astral is designed
to address todays needs in proteomic analysis. The instrument excels at deep sequencing and quantitative
proteomics as well as accurate characterization of post translational modifications. The current mass
spectrometers in the Core lack fast duty cycles and the advanced ion optics that make detection of low
abundance species routine on the Astral. The ability to unambiguously localize post translational
modifications (PTM) in peptides is a critical feature in any proteomic MS system and the Astral is
outstanding in this due to the high degree of coverage within the identified proteins. Wayne State
University is strongly committed to this proposal as evidenced by a combined $350,000 in new support
for the instruments management, operation, maintenance, informatics and usage. The technical
expertise of Proteomics Core personnel as well as the physical and administrative infrastructures are
all in place and ready to immediately put this new mass spectrometer to work on NIH-funded biomedical
research projects. This instrument will provide transformative technologies for advancing dozens of NIH-
funded, ongoing projects, as well as catalyzing new research directions for investigators at Wayne State
University.

Public health relevance
Project Narrative This proposal requests funds for a state-of-the-art mass spectrometer for identification and quantitation of proteins in biomedical research samples. The system will bring new capabilities to the Proteomics Core Facility at Wayne State University. Knowledge about changes in protein expression, and abundance indicate the status of signaling pathways underlying development and disease. The Orbitrap Astral will provide sensitive and reliable proteome profiling, which will reveal biomarkers for the presence of health and disease.